Rochester-Buffalo Neonatal Research Group

The primary goal of the combined University of Rochester (UR) – University at Buffalo (UB) Center’s participation
in the Eunice Kennedy Shriver NICHD Neonatal Research Network (NRN) is to improve the care of neonates
through conceiving, developing, participating in, and completing large, well-designed interventional and
observational trials that address important clinical questions. The specific aims of this application are:
1. To continue to participate fully in NRN trials by recruiting, retaining, and following a diverse population of
infants in a safe and ethical manner;
2. To afford novel opportunities for neonatal research by sharing our resources and expertise in diverse areas
of investigation, and by generating and leading new clinical trials; and
3. To lead the NRN in adapting to a new era of wider external investigator participation and enhanced rigor in
the evaluation of potential trials.
To realize these aims, UR and UB will continue to participate as a combined Clinical Center with two performance
sites (URUB), an arrangement that has been effective and efficient for over a decade. URUB provides proven
enrollment, management and intellectual capabilities in the setting of strong academic clinical and basic science
faculties with long-standing commitments to clinical trial excellence, large neonatal populations with high rates
of recruitment and retention, excellent University and hospital support, experienced clinical research staff,
established neonatal neurodevelopmental follow-up clinics, well-developed data systems, high-quality maternal-
fetal medicine services, and strong obstetrical-neonatal communication. The URUB Center includes two
geographically-adjacent NICUs, each with large neonatal populations, to increase subject availability, and draws
on the intellectual excellence of two respected academic neonatal divisions. The Center has consistently ranked
in the first or second quartile of NRN centers for number of infants enrolled in clinical trials, and ranks 6th in size,
as measured by enrollment in the generic database (GBD) of infants <29 weeks’ gestation.
With an eye to the future, the Center has already been instrumental in planning to accomplish NICHD’s stated
goals of enhancing rigor and reproducibility through NIH peer review of all new protocols, promoting greater
availability of multisite clinical trial infrastructure to support trials from a wider range of investigators
through a more open, inclusive mechanism for study proposals, facilitating data sharing and access to
biospecimens through timely deposit of data and biospecimens into the NICHD Data and Specimen Hub
(DASH) and similar repositories, and facilitating greater involvement of diverse populations in multisite
clinical trials through continued enrollment of racially, socially and economically diverse participants.
The URUB Center’s intellectual, organizational and operational strengths will allow it to lead and participate
substantially as the NRN expands into new, previously unexplored areas of research.

Public health relevance
The Neonatal Research Network (NRN) is an excellent platform for conceiving and completing large, well- designed clinical trials. The NRN has a strong track record of impactful research and ongoing randomized clinical trials in a number of areas of neonatal medicine. The URUB Clinical Center has the leadership, enrollment and follow-up capabilities to continue to be an excellent venue for future, similar successes and has unique, specialized resources and expertise to facilitate cutting-edge research.